Imaging Core

ABSTRACT - IMAGING MODULE
The Imaging Module basic science and clinical components provide a range of (i) basic science imaging (TEM,
confocal, scanning optical); (ii) ex vivo and in vivo pre-clinical and clinical imaging; and (iii) computing services
(imaging, database, mathematics) based on strengths of core laboratories and the tradition of excellence of the
UU School of Computing, Collaborations among these groups have transformed software tools for TEM and
confocal imaging. Note that any human subject image acquisition will be under IRB-approved protocols funded
by non-core NIH grants; Imaging Core resources will be used for advanced image and data analysis.